Robot-Enabled Natural Orifice Prostatectomy

Project Summary/Abstract:
The objective of this proposal is to create a hand-held surgical robot for endoscopic transurethral radical
prostatectomy. The new robot will deploy needle-sized arms through the endoscope, for independent tissue
manipulation, laser aiming, and visualization, enabling resection of the prostate and reconstructive suturing.
Clinical signiﬁcance comes from (1) the large number of patients who could beneﬁt (1 in 7 men will have
prostate cancer in their lives; 161,000 new cases per year in the USA; 90,000 surgeries per year in the USA),
and (2) the high morbidity of current surgical approaches (70% impotence, 21% incontinence, with 39% requiring
a subsequent intervention to address complications, and a 1 in 5000 mortality rate). We hypothesize that the
key to reducing rates of impotence, incontinence, and complications is minimal disruption to the delicate tissues
surrounding the prostate, especially the neurovascular bundles that run on the outside of the prostate and control
erectile function and the external sphincter that enables continence. Yet current surgical techniques approach
the prostate from the abdomen, and thus require large dissection of the structures that surround the prostate in-
cluding endopelvic fascia and prostatic ligaments, and manipulation and retraction of the neurovascular bundles.
In contrast, we propose the novel approach of reaching the prostate from within, through the urethra, which is
enabled by needle-size, tentacle-like robot manipulators delivered through an endoscope, to enable laser-based
resection and dexterous reconstructive suturing. We hypothesize that such a system will improve functional out-
comes and reduce complication rates, providing a much less invasive approach to performing prostate surgery.
The innovation of our new robot is the ability to deliver needle-sized robotic arms through an endoscope. They
are made up of telescoping, curved, elastic tubes. By axially rotating these tubes and telescopically extending
them, our robot will provide the surgeon with two small tentacle-like arms at the tip of the endoscope. One arm
will carry a holmium laser ﬁber for cutting, the other will enable tissue retraction, and both will work together to
perform reconstructive suturing. This is the ﬁrst hand-held robotic system to provide two-handed dexterity. It will
enable suturing within a lumen as small as the urethra, a major technical innovation that we expect to be useful
in many other surgical contexts in the future.
Our approach consists of three Speciﬁc Aims. Aim 1 addresses the mechanical design of a sterilizable, hand-
held robotic system suitable for the workﬂow of a real-world operating room. Aim 2 focuses on designing con-
centric tube manipulators with novel needles and graspers at their tips that enable reconstructive suturing (anas-
tomosis) from within the lumen to be repaired. Aim 3 consists of phantom, ex vivo animal tissue, and cadaver
studies to experimentally validate our new transurethral approach to radical prostatectomy, evaluating resection
quality via medical imaging and reconstruction quality via ﬂuid testing.

Public health relevance
Narrative: Public Health Relevance Prostate cancer is the most common cancer in men, with 1 in 7 men suffering from it in their lifetime, and 90,000 men per year undergoing surgery with high complication rates and poor functional outcomes (70% impotence and 21% incontinence). We hypothesize that it is the large amount of dissection and manipulation/retraction of nerves and other delicate tissues that is responsible for these complication rates, and that the key to improving them is to reduce the invasiveness of the procedure. To accomplish this, we propose a new robotic system that enables transurethral removal of the prostate and reconstructive suturing.